TGF-β Superfamily Conference: Signaling in Development and Disease

Abstract
The FASEB SRC TGF-β Superfamily: Signaling in Development and Disease Conference in 2024 (hereafter
“TGF-β 2024”) will bring together investigators who are leaders in a variety of interconnected and interrelated
disciplines that intersect through a key role of TGF-β signaling in the process. Bringing together such a diverse
group of scientists is essential for a comprehensive understanding and assessment of the TGF-β signaling axis
in development, homeostasis, regeneration, aging, injury, and disease. The scientific presentations, formal and
informal discussions, and poster presentations throughout the conference are designed to expand the
understanding of the genetic, molecular and cellular mechanisms and processes by which the TGF-β signaling
axis influences development and maintenance of organ systems, and to uncover how deregulation of this
control results in disease. This knowledge is fundamental to understand how TGF-β signaling pathways are
regulated and how they execute their functions under normal conditions in restoring the homeostasis of the
body and facilitating successful tissue repair and regeneration. TGF-β 2021 will leverage new and important
findings and provide attendees with: a broader appreciation and perspective of the complexity of the TGF-β
signaling axis; examples of therapeutic strategies being tested and opportunities for considering and
discussing future ones. This is the 13th FASEB TGF-β conference. The field of TGF-β signaling has been
rapidly advancing and expanding; in particular, almost 10,000 articles per year related to
TGF-β/BMP/GDF/Activin/Nodal have been published in the past five years. This fast pace warrants the
convening of this conference and ensures its success. TGF-β 2024 takes pride in the strong tradition of
collegiality of conference attendees and, most importantly, the collaborations that are generated through this
conference. The collective experience built over the previous twelve conferences has provided us with the
confidence that TGF-β 2024 provides a forum for extended discussions and conversations, interactions,
networking, debating of novel hypotheses and prioritization of unmet research or therapeutic needs, and career
training/advice particularly for young investigators and trainees from diverse backgrounds who represent future
researchers in this field.

Public health relevance
Project Narrative TGF-β family signaling pathways act as central mediators of embryonic development, organ homeostasis, and the body's ability to repair successfully after injury. Importantly, perturbations in the TGF-β signaling axis are linked to a long and growing list of diseases of cardiovascular, respiratory, and skeletal systems, a multitude of cancers, and physiological changes during aging, providing fertile ground for the identification of novel targets and promising new therapies that can fundamentally impact the health of a broad segment of the population. The 2024 FASEB SRC TGF-β Superfamily Conference: Signaling in Development and Disease aims to exploit these exciting discoveries and provide a timely and relevant forum for their presentation, appreciation, analysis, and discussion to inspire and stimulate progress toward ever more effective and targeted therapeutics for TGF-β signaling disorders, while promoting the career development goals of participants, particularly those who are early career scientists, new to the TGF-β field, and/or members of underrepresented groups.